Circadian Timing, Sleep, and Adiposity

DESCRIPTION (provided by applicant): This application for a Mentored Patient-Oriented Research Career Development Award entitled Circadian Timing, Sleep, and Adiposity is being submitted by Dr. Kelly Glazer Baron, PhD, MPH, to continue her professional development as a clinical researcher in sleep and circadian rhythms. Obesity is one of the nation's greatest health problems and sleep and circadian rhythm disturbances are thought to play a role in the development of obesity. Short sleep duration and poor sleep quality have been shown to affect metabolism and the hormones that regulate hunger and satiety. In addition, disrupted circadian rhythms, such as in shift work, have been associated with weight gain, increased risk for metabolic syndrome, poorer diet and exercise behavior. At this point, it is not known to what degree individual differences in circadian timing contribute to obesity in non-shift workers. This study will test the timing of circadian rhythms and also the alignment between circadian rhythms and sleep with measures of adiposity, dietary behavior, and physical activity. Results of this study may lead to new interventions for the prevention and treatment of obesity. Dr. Baron is a Clinical Health Psychologist with a specialty in Behavioral Sleep Medicine. Her research has focused on health behaviors in sleep disorders populations, including treatment adherence in obstructive sleep apnea and outcomes of insomnia treatment. She has been building her knowledge and experience with circadian rhythms research through evaluating dietary behavior in individuals with normal and delayed sleep timing preferences. The project proposed in this award builds on Dr. Baron's prior research demonstrating greater calorie intake in those with a preference for later sleep timing by objectively measuring circadian rhythms and also exploring the effects of misalignment between circadian rhythms and sleep. Her long term goals are to become an expert on the role of circadian rhythms in metabolism and weight regulation, with understanding of both the biological and social aspects of this relationship. It is Dr. Baron's hope that this work will lead to interventions to prevent and treat obesity through new mechanisms, such as shifting circadian rhythms using behavioral changes, light and melatonin.

Public health relevance
Project Narrative Individuals with delayed circadian rhythms may have disrupted metabolism and increased risk of weight gain due to both biological and social factors, such as what is seen in shift workers. The proposed project will evaluate associations between timing of the circadian rhythm and misalignment of the circadian rhythm and sleep with obesity, diet, and physical activity. If results demonstrate that circadian timing and or misalignment are associated with obesity, this research may benefit public health through leading to new biological and behavioral interventions for obesity that involve shifting circadian rhythms using behavior, light, and melatonin. __SpecificAimsTextDelimiter__ 10. Specific Aims Obesity is one of the nation's greatest public health problems and a major factor in the development of cardiometabolic disease. There is growing evidence of the contribution of both the duration and timing of sleep to the obesity epidemic. In particular, shift workers are at increased risk for weight gain and metabolic syndrome due to short sleep duration and circadian misalignment.7 Furthermore, recent animal research has demonstrated increased weight gain in mice fed during the time they normally sleep (light) versus mice fed when they normally eat and are active) despite similar caloric intake and activity, suggesting the alignment of sleep and circadian timing may be important to weight regulation.8 A fundamental question in the field remains; to what degree do individual differences in circadian timing and alignment contribute to obesity above and beyond sleep duration? Our preliminary data suggest individuals with preference for later sleep and wake timing have higher BMI, consume more daily calories, more fast food and fewer fruits and vegetables. However, circadian markers were not evaluated in this study. The mismatch between circadian rhythms and sleep timing (i.e. phase relationship) may be an important mechanism linking sleep timing to obesity risk. We propose that individuals with later circadian timing are at increased risk for obesity due to misalignment of the circadian rhythm with the sleep/wake cycle, similar to that seen in shift work. The misalignment in shift work is caused behaviorally by the individual working during a time normally used for sleep. In the case of later circadian timing, circadian misalignment may be caused by the need to sleep and wake at an earlier circadian time in order to function on a typical work schedule. This hypothesis is supported by recent laboratory data from a forced desynchrony protocol demonstrating lower leptin and impaired glucose as a result of misaligned sleep and wake periods.9 The goal of the project is to evaluate the relationships between circadian timing and misalignment with adiposity and obesity-related behaviors. Circadian timing will be determined by dim light melatonin onset (DLMO) and circadian misalignment will be defined as the phase relationship between DLMO and midpoint of sleep greater or less than the average of 6 hours. Several studies have demonstrated the phase relationship between DLMO and the midpoint of sleep is shorter in individuals with later sleep and wake timing compared with average sleep timing, demonstrating those with later circadian timing sleep at an earlier time relative to their circadian timing.10-11 I will recruit adults (ages 18-45) with adequate sleep duration (6.5-8.5 hours) and a range of sleep timing preferences. Adiposity will be measured by BMI and body composition using dual energy e-ray absorptiometry (DXA) and waist circumference. Dietary behavior will be assessed using food diaries and a food frequency questionnaire. Physical activity will be accessed via actigraphy. The study will achieve the following Specific Aims: Specific Aim 1 To test the hypotheses that later circadian timing (DLMO) is predictive of greater adiposity and poorer dietary behaviors Hypothesis 1.1 Later circadian timing will be associated with higher BMI, a greater percentage body fat, and larger waist circumference. Hypothesis 1.2 Later circadian timing will be associated with greater total calorie intake, fewer servings of fruits and vegetables and greater frequency of fast food. Specific Aim 2 To test the hypotheses that greater circadian misalignment is predictive of greater adiposity and poorer dietary behaviors Hypothesis 2.1 Circadian misalignment will be associated with higher BMI, a greater percentage body fat, and larger waist circumference. Hypothesis 2.2 Circadian misalignment will be associated with greater total calorie intake, fewer servings of fruits and vegetables and greater frequency of fast food. Exploratory analyses: I will conduct exploratory analyses to test the associations between circadian timing and circadian misalignment with two variables that may also impact energy balance and dietary behavior: physical activity and hunger/food preferences. Physical activity will be assessed using actigraphy and hunger/food preference will be assessed by visual analogue scale. The overall impact of this research program will be to move toward the development of new bio-behavioral interventions for obesity, including aligning circadian rhythms, feeding, and sleep. Given that later sleep timing is common in young adults, this research has important implications for intervening on mechanisms of weight gain. This study will lay the foundation for future controlled human experiments to determine mechanisms with the ultimate goal of developing novel behavioral interventions for the prevention and treatment of obesity, thus leading to the prevention of cardiometabolic disease.